Clinical Research in ALS and Related Disorders for Therapeutic Development (CReATe)

PROJECT SUMMARY (Overall)
The Clinical Research in ALS and related disorders for Therapy Development (CReATe) Consortium is a Rare
Diseases Clinical Research Consortium (RDCRC) that forms part of the National Institutes of Health Rare
Diseases Clinical Research Network (RDCRN). CReATe comprises a multi-disciplinary group of clinicians,
scientists, educators, patient advocacy groups and other strategic partners, and aims to advance therapeutic
development for patients with amyotrophic lateral sclerosis (ALS) and related disorders including ALS-
frontotemporal dementia (FTD), progressive muscular atrophy (PMA), primary lateral sclerosis (PLS),
hereditary spastic paraplegia (HSP), and multisystem proteinopathy (MSP). We recognize that the obstacles to
therapeutic development are multifactorial and include: (a) etiological and biological heterogeneity; (b)
phenotypic heterogeneity; (c) limitations of existing clinical outcome measures for use in early-to-mid phase
clinical trials; (d) a paucity of biomarkers that have been validated as “fit for purpose”); (e) the relatively late
stage at which symptoms appear, diagnosis is made, and treatment is initiated; and (f) barriers to patient
participation in clinical research studies. CReATe investigators are engaged in a range of clinical trial
readiness activities that aim to overcome these obstacles, and to thereby advance therapeutic development for
this group of rare diseases. In addition, CReATe aims to promote and support collaborative research in the
field of ALS and related disorders; develop and disseminate resources such as the CReATe Biorepository and
our electronic health record-based ALS Toolkit that are of value to the broader scientific community; lower
barriers to patient participation in research; cultivate and enhance the careers of young clinical investigators
and translational scientists dedicated to the study of this group of rare diseases; and engage both lay- and
scientific-community stakeholders in a partnership that fosters efforts to develop treatments for patients
afflicted with these rare diseases.

Public health relevance
NARRATIVE ALS, ALS-FTD, PLS, HSP, PMA and MSP are rare diseases characterized by degeneration of motor and frontotemporal neuronal systems; effective therapies for these related disorders are sorely needed. Disease heterogeneity, a paucity of biomarkers, delayed diagnostic and treatment, and relatively low rates of patient participation in research, have hampered therapeutic development efforts. Through a series of clinical trial readiness activities, the Clinical Research in ALS and related disorders for Therapy Development (CReATe) Consortium aims to overcome these obstacles and thereby to advance therapeutic development for this group of rare diseases.